Investigation of Self-Nucleic Acids as a Trigger for Neuroinflammation

PROJECT SUMMARY
Pattern recognition receptors (PRRs) are an essential component of the innate immune system responsible for
detecting invading pathogens and activating appropriate immunological responses. A significant proportion of
PRRs are specialized in detecting viral DNA or RNA. Since DNA and RNA are the basic building blocks of life
across all species, an intriguing and widely unexplored question emerges: Can PRRs detect endogenous (self)
DNA or RNA, and what is the biological significance of self-nucleic acid detection? My laboratory at Columbia
University seeks to understand the biological significance of self-RNA sensing by PRRs during both homeostasis
and disease, and to further elucidate how self-RNA sensing is regulated to prevent autoimmune disorders.
Research on Aicardi-Goutières syndrome (AGS) uncovered the causal role of self-nucleic acid mediated PRR
activation in autoimmunity. AGS symptoms `mimic' viral infection, as patients exhibit elevated levels of type I
interferon (IFN), a potent antiviral cytokine produced when PRRs detect viral nucleic acids. Mutations in the RNA
editing enzyme ADAR1 can cause AGS. ADAR1 introduces A-to-I edits in cellular double-stranded RNAs
(dsRNAs), and prior studies demonstrated that ADAR1 deficiency leads to aberrant activation of PKR and MDA5,
two PRRs widely known to sense viral dsRNAs and trigger potent antiviral immune responses. These findings
gave rise to the idea that during ADAR1 deficiency, self-RNAs become mistaken as viral RNAs, triggering PRR
activation and downstream antiviral and inflammatory responses. Intriguingly, AGS mainly affects the brain,
where elevated type I IFN production is observed, and most patients are left with mental and physical disabilities
due to damage to the brain. ADAR1 and many PRRs are ubiquitously expressed in all cells, but it is puzzling
why the neural compartment is particularly vulnerable to dysregulated inflammation. Currently the underlying
molecular mechanisms that predispose the brain to inflammation are poorly defined. Our long-term goal is to
define the role of self-RNAs in triggering neuroinflammation. We will determine if dsRNA sensing PRRs
contribute to constitutive type I IFN expression in human neural cells, including neurons (Aim 1). Then, we will
determine the abundance and subcellular localization of dsRNAs in neurons: during homeostasis and RNA
dysregulation (Aim 2). We will also elucidate the molecular mechanism by which ADAR1 restricts self-RNAs from
activating PRRs in neural cells (Aim 3). In this application our rich experience in immunology and RNA biology
will be applied to neurobiology. We will utilize cutting edge human stem cell technology, neural cell differentiation
techniques, and high-throughput genomics in collaboration with leading experts in their field. These studies can
help identify early molecular events that trigger inflammation in the brain, which may lead to discovery of new
therapeutic targets to treat AGS. More broadly, these studies may provide insight into how inflammation arises
in other neurodegenerative diseases such as ALS (amyotrophic lateral sclerosis) or frontotemporal dementia
(FTD), where perturbation of RNA-binding protein dosage or expanded RNA repeat elements can cause disease.

Public health relevance
PROJECT NARRATIVE The goal of this study is to identify early molecular and cellular events that trigger inflammation in the brain. We will investigate the mechanism of how RNA cytotoxicity triggers neuroinflammation. These studies may lead to discovery of new therapeutic targets to treat neuroinflammatory and neurodegenerative disorders.